Sample Procurement and Management Core

PROJECT SUMMARY/ABSTRACT SAMPLE PROCUREMENT AND MANAGEMENT CORE
The main function of Sample Procurement and Management Core (SPMC) is to provide Research Projects 1
and 2, the Technology Development project and the Microbiome Core with human specimens to support the
proposed research of this CCHI. The SPMC has four Specific Aims:
AIM 1: Finalize program-specific operations to receive and manage samples.
AIM 2: Oversee sample collection, acquisition and processing.
AIM 3: Manage sample storage, tracking and distribution.
AIM 4: Oversee personnel training and compliance.